Iowa-Diversifying Research And Mentorship (iDREAM)

Project Summary/Abstract
The future of Neuroscience must include representation of all people; such diversity is crucial to fuel the
innovation required to meet current scientific and healthcare challenges facing neuroscientists. In response to
RFA-NS-22-035, we propose a Doctoral Readiness training program – the Iowa Diversifying Research And
Mentorship (iDREAM) program. The iDREAM program leverages the power of (1) an outstanding
Neuroscience Graduate Program with long-running T32 support (JSPTPN), and (2) a strong institutional unit,
the Iowa Neuroscience Institute, which supports rigorous culturally aware faculty development and will provide
crucial administrative support for iDREAM. We have formed a compelling MPI leadership plan with a blend of
experience, skills sets, and energy. We will train four iDREAM post-bac scholars per year, for two years each,
drawn from a large pool of applicants from backgrounds underrepresented in Neuroscience and schools
without substantial research opportunities. Our Neuroscience Graduate Program is regularly composed of
>20% URM students and has a stellar track record of training future tenure-track faculty (>50%). iDREAM
scholars will be introduced to Neuroscience research via high-quality, hands-on research experiences in the
laboratories of carefully selected preceptors with manifest commitments to the iDREAM mission. Scholars will
receive rigorous training in the responsible conduct of research, evidence-based didactic training in the critical
thinking and communication skills necessary for a successful research career, and programmatic experiences
designed to cultivate an inclusive environment and sense of belonging within the local and global
Neuroscience communities. iDREAM scholars will partner with grad students in the Neuroscience Program for
near-peer mentorship experiences. Faculty research mentors are 28 well-funded neuroscientists with culturally
aware mentorship training and experience, who reflect the spectrum of gender, background, rank, and
neuroscience research topics and approaches. The mentors will be matched with trainees through a guided
interview process with careful oversight from the MPIs and Executive Committee. iDREAM scholars will attend
career development workshops, weekly scientific seminars and laboratory meetings, and present their
research at multiple local and one national meeting per year. iDREAM scholars will also be guided through all
aspects of the graduate school application process. Long term goals of the program include: 1) empowering
URM post-bac trainees to be competitive at rigorous, top-tier graduate programs in Neuroscience (including at
Iowa) and to lead successful scientific careers; 2) catalyzing progress of enhancing inclusive excellence within
the Neuroscience community at Iowa and beyond; and 3) reinforcing and strengthening existing partnerships
between the Neuroscience community at Iowa and schools without substantial research opportunities. Metrics
of success include the number of participants who apply for and are accepted in a rigorous neuroscience
graduate program, and students reporting a strong sense of belonging in the Neuroscience community.

Public health relevance
Project Narrative (3 sentences) This doctoral readiness program, Iowa Diversifying Research Experiences And Mentorship (iDREAM), capitalizes on an outstanding T32 supported (JSPTPN) Neuroscience Graduate program with a highly successful track record of training neuroscientists from diverse backgrounds, particularly those from backgrounds underrepresented in STEM. It integrates an outstanding interdisciplinary neuroscience research environment with evidence-based practices designed to cultivate self-efficacy and a strong sense of belonging within the local and global neuroscience research communities. In doing so, iDREAM is designed to provide high quality research experiences and didactics to post-baccalaureate students from institutions that do not offer undergraduates substantial research opportunities, ultimately empowering trainees to be competitive for and successful in rigorous, top-tier neuroscience graduate programs and beyond.